Commercialization of the Head Up CPR System for Improving Survival after Cardiac Arrest

Abstract
Sudden cardiac arrest (SCA) is a leading cause of death in the USA, with only 3-20% neurologically intact
survival for >350,000 out-of-hospital SCA patients each year. Even after patients are initially resuscitated, many
die within a week from severe brain injury. The goal of this application is to improve neurologically-intact survival
rates after pre-hospital and in-hospital SCA through the commercialization of a novel method of CPR called
Head Up Position (HUP) CPR. HUP CPR works by harnessing gravity to enhance venous blood flow from the
brain to the heart, lower intracranial pressure, and enhance cardiac output. The first clinical HUP CPR device,
the ELEGARDTM, was designed, built, and tested with Phase I funding support. The ELEGARD has been used
to help treat >4500 SCA patients to date. Based upon early positive clinical outcomes, Phase II funding supported
the development of a refined and more portable device to accelerate adoption (ELEGARD 3.0). A subsequent
limited launch evaluation in 2024 was highly favorable. However, it revealed a compatibility issue where some
shorter patients were slipping out of position during elevation, likely due to experiencing greater head and thorax
elevation compared to taller patients. As a result, post-award efforts have focused on refining the head cradling
mechanism to ensure consistent head elevation and minimize slippage for patients of all heights. Additionally,
during this period, the device’s contract manufacturer suddenly closed, requiring the transfer of ELEGARD 3.0
assembly and processes to a new production facility. This transition requires significant additional resources to
integrate the device into a new production facility and quality system. Given that the SBIR CRP program supports
late-stage development activities, Resuscitation Innovations (RI) hopes to secure funding to 1) Optimize,
manufacture, and validate an updated ELEGARD 3.0 head cradling mechanism and carrying case; and 2)
Transfer manufacturing of ELEGARD 3.0 to a new ISO13854 certified production facility and complete process
validations and design control transfer for commercial launch. Successful completion of these aims will
accelerate commercialization and adoption of this innovative technology to improve neurologically-intact survival
rates after SCA.

Public health relevance
Project Narrative The overall goal of this application is to improve neurologically-intact survival rates after sudden cardiac arrest (SCA). Still a leading cause of death, less than 10% of the more than 350,000 pre-hospital SCA patients in the US each year survive with favorable neurological function. Survival rates for the more than 300,000 in-hospital SCA patients is similarly poor. CRP funding will support the final steps in the commercialization of a compact and portable novel Head Up Position (HUP) CPR device that accelerates clinical adoption of this novel SCA technology.